Administrative Core

REVISED ABSTRACT:

Administrative Core: Project Summary – 2P30AG066444-06 (5151)
This Core provides coordination and integration for all other Components and acts to ensure that the research and programmatic goals of the Center are met. The administrative leadership consists of the Director, the Associate Director, and the Executive Director; three other faculty join them in forming the Knight Alzheimer Disease Research Center (ADRC) Executive Committee. They are assisted by the Leadership Committee that includes these individuals, Leaders of all ADRC Components, and other senior faculty. The Administrative Core supports, monitors and coordinates the activities of all Components of the ADRC. 1. Establish and maintain administrative structure and governance, including budgetary management, future planning, and optimal resource utilization, to meet the overall goals of the Center. 2. Coordinate and integrate all ADRC activities and Components for research, training, information (including data, biospecimen, and imaging) transfer, and resource sharing with independent investigators both internal and external to Washington University (WU). 3. Promote scientific and educational interactions (including public relations) and collaborations on Alzheimer disease (AD) and related dementias (ADRD) at all levels (emphasizing junior investigators) with other faculty at WU, other ADRCs, the National Institute on Aging (NIA), the Alzheimer’s Association (locally and nationally), and the professional and lay communities of the greater St. Louis area. 4. Solicit, evaluate, select, and monitor the Developmental Projects. 5. Provide for periodic external review of the Knight ADRC by its External Advisory Committee and achieve internal review. 6. Ensure compliance with all regulatory requirements for human subjects research, animal welfare, scientific integrity, data and sample sharing, public access policies, and financial policy requirements of WU and the National Institutes of Health (NIH). Core A also will monitor and regularly assess how other Knight ADRC components are responsive to NAPA goals.